The Impact of WDR36 Variants and p53 in Glaucoma

PROJECT SUMMARY
Primary Open Angle Glaucoma (POAG) affects three million people in the US, with nearly half unaware they
have the disease. Major risk factors include elevated intraocular pressure, age, and genetics, with genetics
increasing the risk of developing POAG by almost ninefold. The discovery of genes associated with POAG
can not only be used to help predict a patient’s risk but also enables earlier diagnosis and development of
treatments targeting the underlying biology of the disease. This research focuses on understanding how
variants in the WDR36 gene contribute to glaucoma and whether retinal ganglion cells (RGCs) harboring
mutations in this gene respond to gene augmentation. Although WDR36 variants are present in 5.6% of POAG
patients (compared with 1% in controls), certain variants are associated with more severe and early-onset
disease. Investigating these variants is critical for understanding disease mechanisms and calculating disease
risk. Our central hypothesis is that variants of WDR36 worsen RGC loss by disrupting ribosomal assembly,
increasing sensitivity to p53-driven cell death during aging and with elevated intraocular pressure. Our study
focuses on the WD40 domain of WDR36, which plays a role in ribosomal assembly and may trigger early RGC
death via the p53-MDM2 anti-apoptosis pathway. We have developed a mouse model with a WDR36 mutation
that demonstrates an age and IOP-dependent phenotype of the disease. We will also use human stem cells
from non-glaucomatous eyes and cells with clinically relevant mutations in the WDR36 WD40 domain to
differentiate into RGCs to study how mutations in the WD40 domain influence cell survival and morphology.
Additionally, we’ve created viral vectors to test if gene augmentation therapy can stop the progression of the
disease phenotype and reverse pathologic mechanisms. To test this hypothesis, we will use mouse and
human models to investigate the role of the variants on cell morphology and survival, as well as whether the
augmentation with normal WDR36 alleviates or slows disease progression (Aim 1). Using stem cells
differentiated into RGCs, we will explore how WDR36 variants interfere with the p53-MDM2 pathway, which
regulates cell death but has not been well-studied in RGCs (Aim 2). By manipulating this pathway through
gene augmentation and specific inhibitors, we aim to slow or prevent early RGC degeneration in patients
harboring these mutations. In addition to providing a framework for studying other genetic forms of POAG, this
specific project will help us better understand the genetic mechanisms behind a genetic form of POAG and
assess the potential for gene therapy to treat it.

Public health relevance
PROJECT NARRATIVE The proposed research aims to explore the significance and underlying mechanisms behind the increased risk of primary open-angle glaucoma (POAG) in patients with variants in the WDR36 protein, using human cell lines and a mouse model and possibility for treatment with gene augmentation therapy. Our proposal will test the hypothesis that mutations in WDR36 lead to increased sensitivity and early apoptosis by destabilizing the p53- MDM2 pathway, and that early gene augmentation can correct this mutation. The findings may also help predict glaucoma risk in patients with germline variants in the WD40 domain of WDR36 and suggest potential mechanisms for early detection and treatment to prevent POAG onset.